Regulation of tRNA fragment biogenesis and function by nucleotide modifications

Project Summary/Abstract
tRNAs are well-known as the physical adaptors of the genetic code, bridging codon-
based information with the appropriate amino acids required for protein translation. tRNA
function can be regulated by a wide variety of mechanisms, including the modulation of
tRNA aminoacylation by cellular amino acid levels. Two previously underappreciated
mechanisms have recently emerged as key regulators of tRNA biology – covalent
modifications of tRNA nucleotides, and cleavage of tRNAs, which generates stable and
potentially functional tRFs.
Here, we propose to investigate the regulation of tRNA cleavage, and the
functions of resulting tRNA fragments, in budding yeast and in mammalian embryonic
stem cells. First, as tRNA nucleotide modifications have been shown to interfere with
tRNA cleavage in several model organisms, we will first survey the effects of all known
tRNA modifications on tRNA cleavage in yeast. Deep sequencing of small RNAs will be
carried out for a large collection of yeast deletion mutants – covering all nonessential
tRNA-modifying enzymes known at present – following overexpression of various tRNA
nucleases. In parallel, we will develop a comprehensive panel of conditional mutants in
tRNA modification machinery in murine ES cells to extend these studies to a mammalian
model.
A complementary effort will focus on the roles for tRNA fragments in translational
control. Again comparing yeast and mammals, we will characterize translation by
ribosome footprinting in wild-type and in mutants lacking tRNA cleavage or various tRNA
modifications. To allow biochemical access to specific tRNA fragment activities, we will
use in vitro translation systems to directly investigate the roles for various purified or
synthetic tRNA fragments at well-defined stages of protein translation.
Together, these experiments systematically address the roles for tRNA
modifications in tRNA cleavage and control of translation by resulting tRNA fragments,
providing important insights with relevance to diseases ranging from neurodegeneration
to cancer.

Public health relevance
Public Health Relevancy Statement/Project Narrative tRNAs are the link required to translate genomic information from RNA copies of the genome into the amino acid sequences that make up proteins. Interestingly, tRNAs are among the most heavily-modified RNAs in the cell, and tRNA-modifying enzymes have been linked to an ever-increasing range of disease processes. In addition, tRNAs often cleaved in response to changes in environmental conditions, and the resulting fragments are increasingly understood to play underappreciated roles in the cell. In this proposal we will systematically investigate the biology of tRNA modification in control of tRNA cleavage and control of protein translation.